Explore the prion pathogenic mechanisms by investigating the structure-function relationships of PrP fibrils

This proposal aims to investigate the pathogenic mechanisms underlying the Creutzfeldt-Jakob disease (CJD).
CJD is the prototypical form of a group of cognitive disorders termed rapidly progressive dementias (RPDs),
which include the rapidly progressive subtypes of classic dementias such as Alzheimer's disease (AD). Sporadic
CJD (sCJD), the most common human prion disease, is characterized clinically by fast cognitive decline with
ataxia, myoclonus or other neurological signs, and neuropathologically by the accumulation of misfolded prion
protein (PrP), spongiosis, gliosis, and neuronal loss. CJD or prion disease is caused by the pathogenic
conversion of the normal cellular PrP (PrPC) to its misfolded and aggregated form, PrPSc or prion. Such
autocatalytic PrPSc-templated conversion results in the spreading and accumulation of PrPSc and leads to
neurodegeneration. All prion diseases, including CJD, are inevitably fatal, and there are currently no prophylactic
or therapeutic remedies available for these devastating disorders. Recent in vitro studies using bacterially
expressed recombinant PrP have generated various groups of self-replicating recombinant PrP amyloid fibrils,
some of which can induce bona fide prion diseases in animal models. Intriguingly, certain misfolded recombinant
PrP fibrils are able to self-propagate in vivo but not cause any disease in animals. Taking advantage of the self-
propagating property of the non-pathogenic recombinant PrP fibrils, the current proposal aims 1) to investigate
the structural differences between pathogenic and non-pathogenic PrP fibrils by cryo-EM; 2) to investigate the
differential glial responses to pathogenic PrPSc and non-pathogenic recPrP fibrils; and 3) to investigate the anti-
prion mechanisms of the non-pathogenic recombinant PrP fibrils against prion diseases. These proposed
structural and functional studies will contribute to the fundamental understanding of the pathogenic mechanisms
of CJD and lay the groundwork for developing novel therapeutic strategies against protein misfolding-associated
neurodegenerative diseases.

Public health relevance
Despite significant advances in prion research, the molecular mechanisms underlying prion-induced neurotoxicity/neurodegeneration remain unclear. The main goal of this proposal is to explore the pathogenic mechanisms in prion diseases by investigating the structural and functional relationships of various types of PrP fibrils. This knowledge will facilitate the development of innovative therapeutics for prion diseases.